Exerkines and the heterogeneity of peripheral and cerebral vascular adaptations to exercise training with aging in women and men

PROJECT SUMMARY/ABSTRACT
Aging is the primary risk factor for cardiovascular diseases (CVD) and Alzheimer's disease and its related
dementias (ADRD),1, 2 due in part to adverse changes in peripheral vascular endothelial3 and cerebral vascular
function,4 respectively (i.e., vascular aging). Regular aerobic exercise (AE) protects against vascular aging by
favorably targeting several pillars of aging (i.e. inflammation, mitochondrial dysfunction, cell senescence,
impaired nutrient sensing and proteostasis) and reducing oxidative stress. However, there is considerable
heterogeneity in the endothelial and cerebral vascular benefits to AE in middle-age and older (MA/O) adults,
including sex differences. The reason(s) for AE response variation are poorly understood but could be related
to age/sex differences in the biological changes underlying vascular aging and/or the molecular transducers
(i.e., circulating exerkines including endothelial microvesicles [EMVs]) that communicate and coordinate the
effects of AE on the vasculature in the periphery and brain. Here, we propose a randomized controlled 12-
week intervention of AE (3 d/week, 60-80% heart rate reserve, ~1 h duration) or non-exercise control in groups
of young (18-39 years), middle-aged (40-59 years) and older (≥60 years) adults, balanced by sex. Outcomes to
be assessed before and after the intervention include: 1) peripheral endothelial function (brachial artery flow-
mediated dilation -- primary outcome), 2) cerebrovascular function (cerebrovascular reactivity to a hypercapnic
stimulus -- primary outcome), and 3) biospecimens: blood and/or vascular endothelial cells assayed for
transcriptomic, proteomic, metabolomic and EMVs and their cargo (e.g., micro RNA) obtained (a) before, (b)
during (blood only) and (c) after acute treadmill AE (40 minutes; 60-80% VO2max) or control period. Aim 1 will
determine if pre- and post-intervention molecular signatures associated with the pillars of aging are associated
with age and sex differences in vascular adaptations to chronic AE training. Aim 2 will determine the influence
of age and sex on the dynamic circulating molecular responses to acute and chronic AE, and their association
with changes in vascular function with chronic AE. Aim 3 will determine if circulating exerkines (e.g., EMVs)
are linked to changes in peripheral and cerebral vascular endothelial cell function with chronic AE, as well as
the corresponding influences of age and sex, by assessing peripheral (aortic) and cerebral endothelial cell
culture nitric oxide, endothelial nitric oxide synthase, and reactive oxygen species production pre-post AE or
non-exercise control after serum or EMV exposure. The proposed research will advance our understanding of
the molecular signals and pathways underlying the systemic and local effects of AE on endothelial and
cerebral vascular function that may explain the heterogeneity in AE responses with age and sex. This
knowledge will allow for the development of personalized age- and sex-specific AE recommendations, and/or
provide insights into molecular targets that can be manipulated to enhance and/or mimic exercise in non-
responders or in persons unable to exercise.

Public health relevance
PROJECT NARRATIVE Regular aerobic exercise is associated with a reduced risk of cardiovascular disease and Alzehimer's disease and its related dementias, due in part to improving vascular health in the peripheral circulation and the brain. Although regular aerobic exercise has been shown to improve vascular health in middle-age/older men it has not consistently improved vascular health in postmenopausal women. The proposed studies will test whether age and sex differences in the underlying biology of vascular aging and molecular transducers with acute and chronic aerobic exercise mediates exercise response variation.